Identification of diagnostic and prognostic host biomarkers of Zika virus infection by transcriptome profiling

PROJECT SUMMARY Identification of diagnostic and prognostic host biomarkers of Zika virus infection by transcriptome profiling There is currently an unprecedented ongoing outbreak of Zika virus (ZIKV) in the Americas, with more than 100,000 cases reported to date. Limitations to existing diagnostic tests include lack of specificity for antibody-based assays and a very narrow time window for PCR (<1 week). Better diagnostic tests are urgently needed to diagnose ZIKV infection. In addition, the weight of the combined evidence now shows that ZIKV is directly responsible for devastating adverse fetal outcomes in infected pregnant women, including in utero demise and microcephaly. There is currently no laboratory test to monitor infected women and assess their risk for fetal complications. Here we propose use transcriptome profiling analysis by RNA-Seq next-generation sequencing of blood, urine, and saliva samples from acutely infected patients to diagnose ZIKV infection, and of serially collected samples from ZIKV-infected pregnant women to monitoring the dynamics of the host response. The goal is to identify diagnostic and prognostic host biomarkers that may be correlated with active infection (for diagnosis) as well as fetal infection and outcomes in pregnant women, and that can be used to develop new assays for monitor ZIKV infection and disease.

Public health relevance
PROJECT NARRATIVE Identification of diagnostic and prognostic host biomarkers of Zika virus infection by transcriptome profiling There is currently an unprecedented emerging outbreak of Zika virus (ZIKV) in the Americas, a mosquito-borne virus that is associated with severe fetal complications such as microcephaly in pregnant women. Better diagnostic tests are urgently needed to diagnose and monitor ZIKV infection. Here we propose to identify biomarkers of ZIKV infection that can be used for diagnosis in infected patients and to monitor fetal infection and outcomes in pregnant women who are infected with ZIKV.